Administration and Data Integration Core

The objectives of the Administration and Data Integration Core (Core A) are three-fold: first, the Core will
provide administrative support and financial management of the Program Project Grant (PPG); second, the
Core will support cross-platform bioinformatics integration and sharing of multi-omic datasets generated by the
Cores and Projects; third, the Core will facilitate interactions between the Cores and Projects, as well as
between Baylor College of Medicine (BCM) and Washington University School of Medicine (WU), and will also
provide overall scientific leadership of the PPG. The Core will be led by Dr. Hui Zheng, Director of the
Huffington Center on Aging (HCOA) at BCM, and housed within the HCOA administrative unit. The Core will
be co-led by Dr. Cristian Coarfa, Associate Professor of Molecular and Cellular Biology and an expert in
integrative analysis and visualization of multi-omic data, who will oversee the bioinformatics and data sharing
aspects of the PPG. To ensure effective management and successful execution of the objectives, a Scientific
Advisory Board (SAB) will be formed upon notification of award that will be composed of three members with
established leadership and scientific expertise in AD, tauopathy, aging, lysosomal biology, proteomics, and
metabolomics. The Core will consult with the SAB for overall program management and scientific direction.
The Core has also recruited individuals from BCM and WU who will offer support on institutional resources and
advice on conflict resolution if needed. The specific aims of the Administration and Data Integration Core are
as follows: 1) Provide overall scientific leadership; 2) Provide financial, administrative, and organizational
support; 3) Perform multi-omics data analysis and integration and ensure rapid public access to the datasets;
4) Generate a web-based first-in-class Aging- and Tauopathy-associated Lysosomal atlas (ATLas) of the
lysosomal proteome and metabolome. Overall, the core is ultimately responsible for the PPG’s success, and
will work with NIH and SAB closely to ensure that the team as a whole achieves its milestones and
deliverables.